Transferring Speed of Processing Gains to Everyday Cognitive Tasks after Stroke

ABSTRACT
Many individuals with cognitive impairment experience decrements in everyday function that can signal
encroaching dementia. For every year that cognitive decline is delayed there is substantial savings in patient
care costs and inestimable savings in quality of life for patients and family members. The prevalence of
cognitive impairment in chronic stroke is approximately 50%. A number of techniques have been found to
improve various aspects of cognition in the training situation. However, their transfer to everyday situations
outside the training setting has been limited as is retention. They are therefore of reduced or narrow practical
value. A cognitive ability that is improved but not used to enhance real-world performance has limited
significance. Pilot work has been carried out here with a novel intervention designed to fill these crucial gaps.
The results are very promising. The purpose of the proposed research is to carry out a randomized controlled
trial (RCT) with a large enough sample to rigorously evaluate these preliminary results.
The new treatment to be tested combines two repeatedly validated rehabilitation methods: the Transfer
Package of CI Movement Therapy and Speed of Cognitive Processing Training. The purpose of doing so is to
produce a marked enhancement in the transfer of cognitive improvement from the training setting to
instrumental activities of daily living (IADL) in everyday situations. Both halves of the new combination therapy
are founded on the investigators' own basic research. In both cases, efficacy is supported by positive results
from multiple single-site RCTs and a large multisite RCT. However, the effect of Speed of Processing Training
has been found to have limited generalization to cognitive-based IADL in everyday situations. In contrast, one
of the main strengths of CI Therapy is that it produces a robust and extensive transfer of treatment effect to
everyday life situations by means, in part, of its Transfer Package. A second strength of the Transfer Package
of CI Therapy is long-term retention of its effect. In our initial work, the Transfer Package procedures that this
lab has used effectively to transfer motor gains from the treatment to everyday setting were adapted to transfer
cognitive gains from the treatment to the everyday setting.
We propose here an RCT with 2 arms: Speed of Processing Training (SOPT) in the lab combined with
the TP (TP+) and SOPT in the lab but without the TP (TP-). Participants will be 120 adults more than 1-year
post-stroke with mild to moderate cognitive impairment. Performance on cognitive-based tasks will be
measured in daily life and in the lab before and after baseline, after treatment, and 6- and 12-months
afterwards. This design will permit rigorous testing of the value of the Transfer Package with an adequate
sample size, objective measurement, blinding, and between-subjects control for amount and intensity of
training and therapist contact.

Public health relevance
Project Narrative Impairment of information processing is a frequent consequence of stroke. Several interventions have been developed to address this impairment but the transfer of gains made in the treatment setting to everyday life and the retention of these gains is limited. The proposed research is designed to begin the process of evaluating a Transfer Package of behavioral techniques designed to result in: 1) transfer of gains achieved in the treatment setting to everyday life, and 2) result in retention of the real-world gains without decrement for at least 1 year.